Clinical CT Imaging for Screening and Subtyping of Pulmonary Hypertension in COPD

Project Summary
COPD remains one of the leading causes of morbidity and mortality in the western hemisphere. Pulmonary
hypertension (PH) remains one of the key complications of smoking related lung disease, the presence of
which leads to increased morbidity and mortality. Treatments for pulmonary arterial hypertension (PAH; Group
1 PH) have led to significant improvements in life expectancy and quality of life but have not had success in PH
associated with COPD. We believe that part of the reason for this is that pulmonary hypertension in COPD
arises from a complex set of mechanisms with only a partial pathophysiologic overlap with PAH. Additionally,
patients with COPD are at significant risk for postcapillary pulmonary hypertension due to elevated left-sided
pressures, which complicate treatment with pulmonary vasodilators used in PAH.
CT imaging is increasingly obtained in smokers and is now often part of a lung-cancer screening of smokers.
Features of pulmonary vascular remodeling have been previously described in pulmonary hypertension. In this
proposal we seek to better understand the changes in the pulmonary vasculature and their relationship to
changes in the lung parenchyma using a comprehensive, advance set of features from CT imaging in patients
with group 1 (PAH) and those with COPD. To accomplish this, we use PVDOMICS cohort, a NIH funded
multicenter dataset of patients with pulmonary hypertension, the MGB cohort, a dataset spanning the
Massachusetts General Hospital/Brigham and Women’s Hospital and affiliated hospitals (MGB) and
COPDGene, a data set of 10,000+ smokers. We additionally another NIH funded cohort, CARDIA, which is a
longitudinal study in a general population to establish normative values in the overall population. All these data
sets have already collected accompanying CT scans. In the first Aim we use data with accurate hemodynamic
diagnosis of PH to find CT features that predict the presence of PH. In the second Aim, we find CT features
that are predictive of significant precapillary remodeling and that are shared with group 1 PH, for which
treatments targeting precapillary PH work well. In Aim 3, we use the baseline and follow-up CT scans from
COPDGene, to study how these CT markers evolve over time in relationship to the patient’s health.
This study leverages data from PVDOMICS, COPDGene and CARDIA, three highly curated NIH funded
datasets, as well as clinical data from two large hospitals with advanced lung programs. The study team has
15+ years of experience in analyzing CT imaging of the lung incorporated into the Chest Imaging Platform, an
NIH funded software package. The PI has developed specific expertise in both COPD and pulmonary
hypertension which is his main clinical focus. The completion of this study will lead to insights in using CT
scans for the noninvasive diagnosis and screening of pulmonary hypertension in nonsmokers and smokers, as
well as a better understanding of the mechanism and clinical impact of PH in smokers.

Public health relevance
Project Narrative Smoking related lung disease leading to COPD continues to be a major source of death and illness in the western hemisphere and is often complicated by pulmonary hypertension, an elevation in the pressures of the circulation of the lung. In this study we look at signs of the development of pulmonary hypertension using CT scans in patients with COPD and examine ways of identifying patients that would be good candidates for further invasive testing and possible treatment. This information can be used to screen smokers for pulmonary hypertension as they often get CT scans for lung cancer screening and identify those who based on CT imaging have similar features to non-smokers with pulmonary hypertension in whom medical therapy has been successful.